Bacterial disruption of neuroimmune pathways in a transparent brain

Project Summary/Abstract
Cells of the immune system, bacteria, and neurons are constantly interacting on every
surface of the human body. Recent studies show that bacteria have evolved mechanisms to
engage with the nervous system, often using the phagocytes that regulate inflammation.
Neuroinflammation, or inflammation in neurological tissue, is thought to contribute to common
neurodegenerative conditions, including Alzheimer's disease and Parkinson's disease, although
the basic mechanisms of neuroinflammation remain incompletely understood. The long-term
objective of this New Innovator Award proposal is to define the molecular mechanisms of
neuroinflammation during infection. The innovation is our adaptation of the cutting-edge
zebrafish molecular toolkit (optogenetics, biosensors, in vivo biotinylation) to host-pathogen
interactions. With this system, we can genetically modify host and pathogen, then observe
bacteria invading the transparent zebrafish brain in real-time. As pathogens, we use
mycobacterial species that activate neuroinflammation in humans (TB meningitis, leprosy) and
in zebrafish. We have also developed new zebrafish brain infection models, using human
pathogens isolated from meningitis patients, in order to determine:
Project 1: How do bacteria invade the brain from the blood?
Approach: Define the endothelial mechanisms of brain invasion and vascular injury.
Project 2: How do host versus pathogen factors drive catastrophic brain inflammation?
Approach: Optogenetic (light-activated) control of phagocytes in vivo.
Project 3: How do host versus pathogen factors injure neurons?
Approach: Identifying infectious mechanisms of neuronal injury using biosensors.
To answer these questions, this proposal combines immunobiology and neurobiology
tools with brain infection models in zebrafish. Using live imaging of zebrafish brain infection,
and genetic modification of fluorescent bacteria, neurons, and phagocytes, the earliest
inflammatory and neurodegenerative events can be directly observed in unprecedented detail.
Completion of this work fulfills two goals. First, it will provide needed mechanistic information
on the host cells and molecules that mediate injury in understudied brain infections that
disproportionately affect people living in poverty. This will support the goal of developing new
therapies that limit brain inflammation. Beyond infection, the basic biological mechanisms of
neuroinflammation, revealed by infection, will likely be relevant to the many non-infectious
neurodegenerative conditions that are characterized by neuroinflammation.

Public health relevance
PROJECT NARRATIVE This project seeks to understand how infection causes inflammation and injury in the brain. This work is relevant to public health because many kinds of infections activate the brain's immune system, which can disrupt blood flow or alter the way neurons communicate with each other. By understanding the basic biology of brain inflammation during infection, we hope to provide needed information to develop treatments that limit brain inflammation, which contributes to the development of many common neurological conditions in humans.